Characterizing the molecular mechanisms of centriole duplication, growth and maturation

PROJECT SUMMARY/ABSTRACT
Centrosomes are organelles used to build microtubule-based protein machines, including mitotic spindles and
cilia. At the centrosome core lies a pair of `mother-daughter' centrioles, barrel-shaped structures that act as the
duplicating elements of the organelle. Normally, the centriole pair duplicates only once each cell cycle and,
during mitotic entry, centrioles recruit a shell of pericentriolar material (PCM) – a process called `maturation' –
from which microtubules grow. Not only are they one of the largest protein complexes in eukaryotic cells but
one of the most ancient of organelles, and have fascinated cell biologists since their discovery in the late 19th
century. During the past 20 years, advances in imaging, proteomics and functional genomic screens have led
to an explosion of discoveries in the centrosome field. At present, we have a complete inventory of the proteins
comprising centrosomes. In our model system, Drosophila, centrosomes assemble from a surprisingly small
number of components (approximately 20). Despite these advances, many important questions remain
unanswered. Although only two conserved master-regulators, Polo kinase and Polo-like kinase 4 (Plk4), initiate
centriole maturation and duplication, respectively, it is not known how they are activated specifically on
centrioles. Also, what are the phosphorylation targets of these kinases and how do they promote centriole
duplication and maturation? How are mother centrioles restrained to spawn only a single daughter once per cell
cycle? How is centriole length controlled? Understanding these processes at the molecular level is important
because alterations in centrosome function or number cause a number of serious pathologies, including birth
defects, ciliopathies and cancer. Plk4 has been the centerpiece of our research program because it is both
necessary and sufficient to induce centrosome overduplication (amplification) when overexpressed, a scenario
observed in cancer cells. We have published a series of studies that have defined Plk4 regulation and identified
several of its substrates. Notably, Plk4 utilizes multiple mechanisms of control to restrain its activity and prevent
rampant centrosome overduplication, using an elaborate combination of autophosphorylation, ubiquitination and
autoinhibition. We continue to pursue two overarching goals: 1) identifying the molecular mechanisms that
suppress centrosome amplification (funded by R01 GM110166) and 2) characterizing the inherent mechanisms
that govern centrosome function and duplication (funded by R01 GM126035). Building on our progress during
the past five years, we propose to extend our studies that will define the mechanisms underlying the five
sequential steps in the assembly process. Specifically, we will determine (i) how a single site of daughter
centriole assembly is selected on mother centrioles, (ii) the composition of the pre-procentrioles and how it forms,
(iii) how nascent daughter centrioles assemble, (iv) how centriole growth is controlled, and (v) the initial steps in
centrosome maturation.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it focuses on discovering and characterizing the evolutionarily conserved mechanisms that control the behaviors of centrosomes and their assembly -- processes that, when dysfunctional, contribute to ciliopathy, birth defects and tumorigenesis. Thus, the project is relevant to a part of the NIH's mission because it will enhance our knowledge as to the etiology of numerous centrosome- related human diseases.